Dendritic excitability of layer 2/3 neocortical pyramidal neurons in awake rats

DESCRIPTION (provided by applicant): The dendrites of many neurons contain voltage-gated channels that turn otherwise passive structures into electrically excitable dendrites. Dendritic excitability enables backpropagation of action potentials from the soma into the dendritic tree and the initiation of spikes in the dendrite and these phenomena play important roles in synaptic integration and in synaptic plasticity. Dendritic excitability has been studied extensively in brain slice preparations and to a lesser extent in anesthetized animals, but little is known about dendritic excitability in awake animals. To understand how ongoing synaptic activity affects synaptic integration and plasticity in vivo, in this project we will directly measure dendritic excitability in awake animals using whole-cell recording and two-photon imaging techniques, using the extent of propagation of action potentials into the dendritic tree as a measure of dendritic excitability. Since these are the first studies to use these high-resolution techniques in awake animals, our studies will provide unprecedented information on dendritic function in awake animals.

Public health relevance
Project narrative The dendrites of many neurons contain voltage-gated channels that play important roles in synaptic integration and in synaptic plasticity, but little is known about dendritic excitability in awake animals, where synaptic integration is performed against a background of ongoing synaptic activity. Here we propose to investigate the effects of ongoing synaptic activity on the dendrites of layer 2/3 neocortical pyramidal neurons in awake rats using whole-cell recording and two-photon imaging techniques. Our studies will be the first to make intracellular measurements of dendritic excitability in awake animals and will therefore provide unprecedented information on dendritic function in awake animals.